Admin Core: Regulation of BRCA-dependent Genome Repair via the 53BP1 Axis

ABSTRACT
DNA double-strand breaks (DSB)s occur upon exposure of cells to ionizing radiation and chemicals in the
environment, and when DNA replication forks become impeded by lesions and obstacles then
subsequently collapse. Two mechanistically distinct DSB repair pathways, namely, homology-directed
repair (HDR) and non-homologous DNA end-joining (NHEJ), are responsible for the removal of the majority
of DSBs. Whereas HDR is mostly accurate, NHEJ, while efficient, often entails loss of DNA sequence
during repair, and can also generate chromosome translocations and replication fork fusions. Failure of
NHEJ or HDR leads to heightened engagement of alternate end-joining (AltEJ) and single-strand annealing
(SSA), highly mutagenic and otherwise minor pathways, as repair tools. As such, the choice of DSB repair
pathway has a major impact on the maintenance of genome stability, preventing neoplastic transformation
of cells, and oncogenesis. Our Program Project brings together seven leading NIH-funded laboratories to
collaborate synergistically in delineating conserved mechanisms of HDR, replication fork repair, and
replication fork maintenance, and how HDR is negatively regulated to favor the use of NHEJ as DSB repair
tool. We have assembled three Shared Resource Cores to provide state-of-the-art services in the
production of high quality protein preparations for mechanistic experiments, biophysical and structural
analyses of protein-ligand interactions and precise measurement of binding constants, as well as cellular
interrogations of mechanisms of DSB repair and replication fork maintenance. Altogether, we are
exceptionally well poised to leverage our deep knowledge of DSB repair mechanisms and leadership to
understand how the tumor suppressors BRCA1-BARD1 and BRCA2 function to promote HDR and to
overcome the HDR restrictive action of the epigenetic mark reader 53BP1 and its associated Shieldin and
CTC1-STN1-TEN1 complexes. As such, our Program Project will not only exert a major impact in
elucidating mechanisms of DSB repair pathway choice and cancer drug resistance, but will also identify
novel targets and pathway pivot points to guide the development of new therapeutic strategies to treat
incalcitrant breast, ovarian and other cancers.

Public health relevance
NARRATIVE Our Program Project focuses on elucidating the mechanistic underpinnings of homology-directed DNA repair (HDR) that is mediated by the tumor suppressors BRCA1-BARD1 and BRCA2, and how the 53BP1 regulatory axis restricts HDR to favor the engagement of non-homologous DNA end joining as a DNA repair tool. We anticipate these endeavors to shed light on how DNA double-strand break repair pathway choice is regulated, help identify predictive biomarkers of cancer therapy response, and ultimately lead to the development of novel therapeutic strategies to treat breast, ovarian and other cancers.